Health Disparities in Hospice in Nursing Homes

In the US, more than 15,600 nursing homes (NHs) provide long-term care to more than 1.3 million elderly
adults, of whom about 20% are racial and ethnic minorities. About 40% of NH residents have advanced
illness, and prior to the pandemic more than 27% of all deaths in those ages 65 years or older occurred in
NHs, making high-quality end-of-life (EOL) care critical. Prior research has found racial and ethnic disparities
in NH EOL care. Hospice, a government benefit, allows for EOL care to be provided by a specialist
interdisciplinary team. Timely hospice enrollment is a best practice and is recommended for NH residents with
advanced illness. However, of those dying in NHs only 1/3 enroll in hospice, and 30% of the enrolled residents
receive hospice care for less than a week. Concerns about disparities in NHs related to implicit bias, systemic
racism, and structural racism increased with the pandemic. During 2020, racial and ethnic minority NH
residents were disproportionately affected by COVID-19 as mortality rose by 32%, yet hospice use decreased
in most states. There are gaps in knowledge about racial and ethnic disparities in NH hospice enrollment, the
quality of hospice care provided, and related EOL outcomes. How the pandemic impacted hospice use and if
any related changes were long lasting is also unknown. To address these gaps, we propose a sequential
explanatory mixed methods study guided by Donabedian's Structure, Process, and Outcomes Quality
Framework and the NIMHD Minority Health and Health Disparities Framework. Our aims are to: 1) Identify
racial and ethnic differences in hospice enrollment and the quality of hospice care provided over time, factors
that influence these differences, and how COVID-19 changed these differences; 2) Identify racial and ethnic
differences in NH EOL outcomes over time, factors that influence these differences including hospice
enrollment and the quality of hospice care, and how COVID-19 changed these differences; and 3) Describe
perceived facilitators and barriers that contribute to hospice use and quality of hospice care in racial and
ethnic minority NH residents. To achieve Aims 1 and 2, we will use administrative and publicly available data
from 2015 to 2024, including the Minimum Data Set and Medicare hospice and inpatient claims (n ≈ 8 million)
of NH residents who died and a subset of this sample who enrolled in hospice (n ≈ 2 million). We will include
all available racial and ethnic categories and comprehensive measures of hospice enrollment, hospice quality
of care, and EOL outcomes. To meet Aim 3, we will purposively sample 16 NHs that vary in location, are
either high or low users of hospice, and ≥ 30% of residents are racial or ethnic minorities. We will conduct
semi-structured interviews with an administrator, hospice care planner, and 2 family caregivers of racial/ethnic
minority decedents (i.e., one that used hospice and one that did not) from each NH. Results from this study
will inform evidence-based policies at the national, state, and NH level and influence practice-based initiatives
that can promote equitable access to high-quality hospice for diverse Americans living and dying in NHs.

Public health relevance
PROJECT NARRATIVE Racial and ethnic disparities impact end-of-life care in nursing homes, including the use of hospice, a government benefit program that provides end-of-life services delivered by an interdisciplinary specialist team. Although hospice decreases illness burden and improves quality of life, there is little information on why it is not used more frequently. By analyzing large national nursing home datasets and examining qualitative data, our study will address this gap and provide evidence needed to promote equitable access to hospice in nursing homes nationwide.